Standing Orders to Improve HPV Vaccination

Each year in the U.S., ≥20,000 women and 14,000 men are affected by HPV-related cancers, including
cervical and oropharyngeal cancer. However, in 2020, only 59% of U.S. adolescents aged 13-17 were up-to-
date for HPV vaccination, and rates for 11-12 year olds, the primary target age group for HPV vaccination
(when the immune reaction is better and before exposure to HPV infection), are even lower. Standing orders
(written protocols that authorize designated members of the healthcare team to vaccinate without first obtaining
a patient-specific physician order) have been shown to work in inpatient settings and for adults, but have not
been evaluated for HPV vaccine, which some parents consider controversial. Also, the ways in which
organizational readiness for change (resources, motivation, staff attributes, leadership support and culture)
moderate the effect of standing orders has not been studied. A physician’s recommendation is correlated with
HPV vaccine acceptance, and we have developed a successful online, interactive, communication education
program that will be adapted to train nurses and staff in addition to physicians. We propose testing standing
orders for HPV vaccine in an Accountable Care Organization (ACO) in Western New York, and assessing
which provider and practice factors moderate the effect of standing orders. Advantages of this setting include a
diverse group of rural, urban and suburban practices, and the ACO provides data infrastructure and analytics
that allow practices to evaluate vaccination rates in real time. Our aims are: Aim 1: Apply mixed methods (in-
depth interviews and practice surveys) to identify provider- and practice-level barriers and facilitators to
implementing SOs for adolescent HPV vaccination; Aim 2: Using a 2-arm cluster randomized trial (n=40
practices), we will assess the effectiveness of standing orders (SO) + HPV communication education
(intervention arm) relative to HPV communication education alone (control arm) on HPV vaccination for 11-17
year-olds. A secondary aim is to measure the implementation of SOs using semi-structured interviews and
surveys; Aim 3: Measure costs and cost-effectiveness of the interventions. If successful, this study will add a
deep understanding of how to make SOs effective to raise HPV vaccination rates.

Public health relevance
Despite an effective HPV vaccine being available in the US since 2006, uptake is well below the Healthy People 2030 goal of 80%. We will test the effect of standing orders plus communication training for providers and staff compared to communication training alone on HPV vaccination rates. The goal is to understand how best to increase HPV vaccination in primary care, to ultimately reduce HPV-related cancers.